2025 AAIP Academic Career Development Workshop

Project Summary / Abstract
This supplemental application to the NIDDK R25 Native American Research Internship (NARI) program
proposes support for an Academic Career Development Workshop at the 2025 Association of American Indian
Physicians (AAIP) Annual Meeting. The workshop will provide NARI alumni and American Indian and Alaska
Native (AI/AN) undergraduate and post-baccalaureate students with research education resources as they
pursue medical and graduate school, and early-career development as physician scientists and biomedical
researchers.
The workshop is designed to offer targeted mentorship, culturally grounded career guidance, and exposure to
NIH-supported research pathways. It will build on the success of the 2024 AAIP Academic Career
Development Workshop, which demonstrated strong engagement and positive outcomes among AI/AN
trainees.
The 2025 program will feature sessions led by NIH leadership, Indigenous faculty, and NARI alumni. Topics will
include mentorship strategies, graduate and medical school preparation, NIH funding mechanisms, and
research careers in diabetes, obesity, and metabolism. Participants will engage in roundtable discussions,
keynote presentations, and interactive networking opportunities designed to foster long-term engagement with
biomedical research and strengthen connections across NARI alumni cohorts.
The supplement will support travel, lodging and per diem for NARI alumni and other eligible AI/AN students,
participation by NARI staff, and evaluation of workshop outcomes. Interactive discussions with AI/AN physician
leaders and NIH program officers will promote culturally sensitive dialogue and peer mentorship.
This initiative complements the parent R25 award by expanding its reach and impact, strengthening the
pathway of AI/AN scientists, and advancing NIDDK’s commitment to increasing AI/AN representation in the
biomedical workforce. It will also serve as a model for integrating research career education with Indigenous
values and community engagement.

Public health relevance
Project Narrative This project will support an Academic Career Development Workshop for American Indian and Alaska Native (AI/AN) students and early-career professionals at the 2025 Association of American Indian Physicians (AAIP) Annual Meeting. The workshop will enhance access to mentorship, research education, and NIH funding pathways, supporting AI/AN trainees as they pursue careers in biomedical research and medicine. This initiative aligns with NIDDK’s mission to promote increasing AI/AN representation in the biomedical workforce with the ultimate goal of improving health in diabetes, obesity, and related metabolic conditions that disproportionately affect this population.